TAS::75 0885::TAS NIAID/DIVISION OF AIDS:CLINICAL SITE AND STUDY MONITORING

to provide comprehensive clinical site and study monitoring services for the NIAID/DAIDS extramural clinical trial research portfolio.